Brief Longitudinal Incident Sentinel Surveillance (BLISS) to End the HIV Epidemic among Persons Who Inject Drugs (PWID)

The endgame for eliminating HIV will become increasingly difficult as transmission persists
among people who inject drugs (PWID). Although San Francisco appears on track to achieve
zero new HIV infections within the next few years, the trajectory among PWID lags behind. The
slower rate of decrease in HIV among PWID may be due to lower levels of awareness and
uptake of pre-exposure prophylaxis (PrEP). Meanwhile, neighboring Alameda County (home to
Oakland) has seen little decrease in the HIV epidemic with outbreaks occurring among PWID. In
addition to HIV, PWID in the United States are experiencing high levels of deaths due drug
overdose. To improve response efforts, data collection systems need to be more rapid and
responsive. We therefore propose to create a new epidemiological data collection system for
PWID in Alameda and San Francisco counties called Brief Longitudinal Incident Sentinel
Surveillance (BLISS). We will recruit 600 PWID (300 each in county) using a novel venue-based
/ peer-referral hybrid method called Starfish Sampling to accrue a cohort and follow them
longitudinally. After HIV testing and an initial questionnaire, participants will be asked to provide
brief monthly updates on several key events related to health and substance use, such as
changes in preventive practices or overdose experiences. Monthly data will be collected through
smart phone and online technologies with in-person options as back up. Selected sentinel
events will trigger “deeper dive” data collection through ecological momentary assessments
(EMAs). The sample size is designed to detect low-frequency events as early warning signals
and to gather sufficient longitudinal data to understand factors influencing health behaviors.
BLISS data will help identify and avert outbreaks, micro-target interventions, and address unmet
care and prevention needs.

Public health relevance
PROJECT NARRATIVE To help end the HIV epidemic, we will develop a new surveillance approach that will obtain early warning signs of outbreaks among people who inject drugs (PWID) in San Francisco and Alameda counties, California. A cohort of 600 PWID will be recruited from the community using outreach and peer referral. Each month, PWID will report on their experiences by smart phone or in-person interviews, including risk and preventive behaviors, use of services, and other events significant to the HIV and drug use epidemics in the US.